Johns Hopkins Statistical and Safety Resource Center-HEAL PAIN ERN

ABSTRACT
The JHU-Tufts TIC is an established, functioning team of multisite trial PIs, experienced
lead managers, administrators, and scientists at both Johns Hopkins University (JHU)
and Tufts University. BIOS, a JHU trials research group, will operationally convene this
group and provide staff to execute the required Statistical and Safety Resource Center
program and its specific assigned tasks in the areas of statistics, safety, and DSMB
management. Our joint expertise, developing and managing trials in these specified
areas extends well beyond the last three years of work on the ongoing HEAL Pain ERN
studies with our group having served as clinical coordinating centers and data
coordinating centers for dozens of large multi-centered clinical trials at various NIH ICs.
Together with our partners at Duke, Utah, and Vanderbilt, we will support the awardee
teams for the new sickle cell trials in the same collaborative and comprehensive manner
that has been demonstrated for the ongoing five trials currently awarded as part of the
HEAL Pain ERN initiative.

Public health relevance
NARRATIVE The NIH has created the Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. Trials will be conducted through the NIH HEAL Pain Management Effectiveness Research Network (HEAL Pain ERN), which will use the infrastructure of the NCATS Trial Innovation Network to provide scientific guidance and coordination of the HEAL Pain ERN Trials. The four innovation centers (3 TICs, 1 RIC) will provide integrated functions for the clinical coordinating resource center, data coordinating resource center, statistics and safety resource center, and recruitment resource center. The Johns Hopkins-Tufts TIC will serve as the statistics and safety resource center.